Medical Scientist Training Program

Project Summary
Case Western Reserve University School of Medicine (CWRU SOM) has provided
integrated MD-PhD training since 1956 with many distinguished alumni, including two
Nobel laureates. The NIH-funded CWRU Medical Scientist Training Program (MSTP)
was started in 1975 (T32 GM07250) and has 107 current students. Research and clinical
training occurs at CWRU and affiliated institutions (University Hospitals Cleveland
Medical Center, Cleveland Clinic, MetroHealth Medical Center and the Louis Stokes
Veteran’s Administration Medical Center). These sites are well equipped for cutting edge
research and state of the art clinical training. The CWRU MSTP curriculum integrates
scientific and clinical instruction in all three phases: both PhD and MD course work during
the first two years, substantial personalized clinical instruction as well as research during
the PhD years, and clinical clerkships, clinical electives and research electives in the final
phase. PhD mentors provide individualized research training. Active mentors are well
supported by NIH research grants or other funding sources; they also have established
research training track records or, in the case of Initial Mentors, will be paired with a
Senior Mentor to insure effective mentoring of trainees and to develop the mentoring skills
of new trainers. Criteria for acceptance of MSTP students include superior academic
performance and evidence of strong commitment and skills for research. Acceptance by
the MSTP automatically admits a student to the SOM and any of the 14 MSTP-affiliated
PhD programs. All CWRU MSTP students receive full financial support for stipend, tuition
and health fees for all phases of the program (8.3 years mean duration), and the program
provides laptop computers and travel awards for students to attend national research
meetings. Numerous MSTP-specific program activities supplement the PhD and MD
curricula. The program emphasizes development of leadership skills through student
governance, faculty mentoring, and student-led program activities.

Public health relevance
Project Narrative The CWRU Medical Scientist Training Program integrates research and clinical training of physician scientists in basic and translational biomedical sciences. Training in these areas can then be applied to a wide range of basic, translational and clinical research. Our mission is to train MD-PhD students for productive careers in biomedical research to fill the national need for future physician-scientists.